ACTG 196--PREVENTION OF MAC BACTEREMIA IN HIV INFECTED PATIENTS

To compare the safety and efficacy of clarithromycin alone versus rifabutin alone versus clarithromycin plus rfabutin for the prevention or delay of MAC bacteremia or disseminated MAC disease.